The effects of pandemic-related stressors on change in CVD Risk: The protective role of universal prevention

ABSTRACT
Although we are not yet in a position to estimate the total collateral damage to health and society due to the
COVID-19 pandemic, widespread increases in stress, financial strain, depression/anxiety, family conflict, and
social isolation during the pandemic may each have large and cumulative long-term impacts on physical
health, particular via cardiovascular disease (CVD). For example, given that evidence from a large recent
meta-analysis indicates that risk for stroke and ischemic heart disease is about 30% higher in lonely and
socially isolated people, the CVD-related “consequences of social distancing may be profound”. Pandemic-
related stressors, such as financial strain and social distancing, may be particularly difficult for families with
young children. In this context, the proposed project is uniquely positioned to examine important theoretical
and practical public health questions that will inform future efforts to minimize the negative collateral health
impacts of infectious disease epidemics as well as other crises: To what extent did the COVID-19 pandemic
increase CVD risk among parents and children? Which of the multiple stressors associated with such a crisis ̶
e.g., financial, mental health, social isolation, family conflict ̶were most strongly linked to increases in CVD
risk among parents and children? Can universal prevention programming enhance parent and child resilience
in order to protect against crisis-related stressors and mitigate crisis-related increases in CVD risk?
Aim 1: To examine the magnitude of change in CVD risk (a) from pre-pandemic to a time point near the
anticipated end of the pandemic (“post-pandemic”) and (b) from the “post-pandemic” time point to 18 months
later. We will assess whether pandemic-period financial strain, mental health problems, and family conflict
predict CVD risk changes. Aim 2. To examine whether random assignment to effective family prevention is
associated with (a) a reduction in the hypothesized increase in CVD risk across the pandemic; (b) greater
“recovery” in CVD health indicators over an 18 month period during which we expect most pandemic-related
restrictions will have been eased; and (c) reduced associations between pandemic-related stressors and
change in CVD risk (moderation). Aim 3: To examine whether gender or pre-pandemic indicators of
socioeconomic status (income, education) moderate the associations examined in Aims 1 and 2.
Impact. This project will result in new practical and theoretical knowledge that is important as we face
increased frequency of infectious disease epidemics and climate change-related environmental disasters.
Research that increases understanding of the stress-related processes within families that impact CVD health
risk will inform future intervention approaches to reduce CVD risk during periods of family crisis, social-
economic dislocation, and natural disasters. Understanding the factors that relate to risk and resilience will
allow program developers to more precisely target salient mechanisms as well as families at highest risk.

Public health relevance
PROJECT NARRATIVE We propose to examine the magnitude of change in parents’ and children’s risk for cardiovascular disease (CVD) from before the COVID-19 pandemic to 18-24 months after pandemic onset (“post-pandemic time point”), and from the post-pandemic time point to a follow-up period 18 months later. The proposed project is uniquely positioned to examine important theoretical and practical public health questions, including: To what extent did the COVID-19 pandemic increase CVD risk among a sample of parents and their children?; which of the multiple stressors associated with this crisis (e.g., financial, mental health, social isolation, and family conflict) are most highly linked to increases in CVD risk in this sample?; and can universal prevention programming enhance parent and child resilience and mitigate crisis-related increases in CVD risk? This research will also inform future efforts to minimize the negative collateral health impacts of infectious disease epidemics – as well as other social, economic, and climate related crises – and will help program developers more precisely target salient mechanisms as well as families at highest risk.